Using EMA to Examine Minority Stress Mechanisms Underlying Cannabis Use among Sexual Minorities

PROJECT SUMMARY/ABSTRACT
Despite often being used legally, cannabis use is associated with several harmful outcomes (e.g., mental
health problems). Moreover, cannabis use is disproportionately higher among sexual minorities (SM) relative to
their heterosexual counterparts. SM who use cannabis are also more likely to develop cannabis use disorder
(CUD) compared to heterosexuals. Our understanding of mechanisms that explain disparities in SM cannabis
use outcomes is nascent. In line with NIDA’s funding priorities to identify mechanisms underlying differences in
SM drug use outcomes, this K99/R00 application aims to evaluate mediators of associations between minority
stressors, cannabis use, and use-related negative outcomes among young adult SM. The minority stress
psychological mediation framework posits that minority stressors result in substance use outcomes through
impaired coping, interpersonal, and cognitive processes. This model has support for SM alcohol use; however,
only eight studies have tested putative mechanisms explaining how minority stressors relate to cannabis use.
Among these studies, many are cross-sectional and most solely test coping motives mediation. Longitudinal
research examining how minority stressors and these mechanisms relate to use and negative outcomes (e.g.,
CUD) is necessary to address these research gaps and advance understanding of SM health. Moreover,
identifying how daily experiences relate to use will provide targets for prevention and intervention development,
particularly when certain experiences (e.g., stigma) may be unavoidable. This K99/R00 study leverages
ecological momentary assessment (EMA) to capture real-time measures in daily life of stressors, cannabis
use, and related outcomes. Foundational work during the K99 phase will collect data to inform EMA item
development (Aim 1), then conduct an EMA feasibility and acceptability study (Aim 2). Dr. Parnes’ training
goals include (1) refine skills to independently design, develop, execute, and analyze EMA research, (2) build
expertise in conducting substance use research with SM populations, (3) continue training in advanced
statistical modeling of EMA data, and (4) promote a successful transition from postdoctoral fellow to
independent faculty researcher. Dr. Parnes’ mentorship team, Drs. Miranda, Mereish, and Treloar Padovano,
are experts in EMA, sexual minority research, and advanced statistical analysis. These training goals build on
Dr. Parnes’ F32 (DA054718), which provided foundational training in identifying mechanisms of behavior
change in adolescent cannabis treatment. Using the protocol finalized through the K00, the R00 study will
conduct a 30-day EMA study among SM who use cannabis to test putative mechanisms relating daily minority
stressors to use-related negative outcomes (Aim 3). Findings from the proposed study will inform whether and
how SM minority stressors relate to harmful use-related outcomes. Evaluating mechanisms can also be used
to identify intervention targets to complement or replace cannabis use, thus reducing liability for CUD or other
negative outcomes, and reducing known health disparities in this population.

Public health relevance
PROJECT NARRATIVE Cannabis use and related negative outcomes are disproportionately high among sexual minorities (SM) relative to their heterosexual counterparts; however, our knowledge of mechanisms portending these health risks is nascent. The goal of this K99/R00 is to leverage daily, real-time measures to examine minority stressors, cannabis use, negative outcomes, and psychosocial factors among SM individuals who use cannabis to evaluate putative mechanisms linking stressors to harmful outcomes. Identifying mechanisms underlying known health disparities will inform when and how cannabis use may be harmful, identify possible intervention targets, and facilitate future detailed examinations of the progression of cannabis use among SM.